CHEMICAL SCREENING AND OPTIMIZATION FACILITY - MANAGEMENT, ADMINISTRATION AND DATABASE CORE FUNCTION ACTIVITIES

This task is to conduct the core administrative activities, including project management, as well as storage of chemical and biological inventory, archived documents and data, maintenance of equipment, and continued database maintenance activities in the Chemical Screening and Optimization Facility (CSOF) to support the mission of contraceptive drug development in the Contraception Research Branch (CRB), NICHD, NIH.

The Chemical Screening and Optimization Facility (CSOF) fulfills a unique role by identifying, optimizing and conducting production identified small molecules for contraceptive and reproductive health related (e.g., infertility, polycystic ovarian syndrome, fibroids, endometriosis, dysmenorrhea, adenomyosis, gynecologic and/or pelvic pain, and vulvodynia, premature birth, placenta health, improving lactation quality and quantity, preeclampsia, perinatal microbiome, gestational diabetes, inflammation, bacterial infections, viral infections, necrotizing enterocolitis, bronchopulmonary dyplasia, pre-term birth, fetal growth restriction, mastitis, Cushing's disease, Down Syndrome, Ricketts, Muscular Dystrophy, Rett syndrome, sepsis, or Autism) research. One approach is to conduct scalable quantity projects of identified small molecule(s) (e.g., natural product) and/or large molecule (e.g., polymer) that afford a contraceptive effect against a validated target or as a treatment for an identified reproductive health related indication. This facility will also be responsible for the production of chemical material for preliminary in vivo testing. It is expected that multiple independent projects will be performed simultaneously by the CSOF. Appropriate oversight of these projects will be essential for their successful execution.